Mechanisms of SPG4 Hereditary Spastic Paraplegia

PROJECT SUMMARY / ABSTRACT
Hereditary Spastic Paraplegias (HSP) are heritable neurodegenerative diseases in which progressive
degeneration of corticospinal axonal tracts results in limb weakness, spasticity and gait deficiencies. These
symptoms result from a dying back pattern of degeneration of corticospinal axons, which also display prominent
swellings of unclear pathological significance. The commonest form of HSP, termed SPG4-HSP, is caused by
mutations in the SPAST gene, which codes for a microtubule-severing protein called spastin. To date, the
prevailing mechanistic hypothesis for the etiology of SPG4-HSP is haploinsufficiency, meaning that the
corticospinal tracts degenerate because of insufficient functional spastin. However, several major disease
features are not readily explained by this etiology, and it is not clear how reduced microtubule severing would
promote corticospinal axonal degeneration. Providing novel information that may fill a major gap in our
knowledge of SPG4-HSP pathogenesis, recent work of the Principal Investigators revealed toxic properties of
mutant spastin proteins, suggesting that a gain-of-function mechanism operates in SPG4-HSP. Curiously, both
mechanisms negatively affect fast axonal transport (FAT), a cellular process fueled by molecular motor proteins
that allows bidirectional movement of vesicular cargoes along axons. Based on a strong experimental premise,
it is hypothesized in this multi-PI grant proposal that abnormalities in microtubule organization associated with
reduced spastin levels cause FAT deficits and axonal swellings (loss-of-function). On the other hand, toxic effects
of mutant spastin protein cause different FAT deficits that are mediated by casein kinase 2 (CK2), and these
deficits promote corticospinal axon degeneration (gain-of-function). The former makes the axon more vulnerable,
but it is the latter that suffices for corticospinal axon degeneration. The proposed work seeks to test these
hypotheses by directly comparing a mouse model with a single SPAST allele (SPAST +/-) with a transgenic mouse
model with both endogenous mouse SPAST alleles intact that additionally expresses human spastin bearing a
pathogenic mutation associated with SPG4-HSP (spastin-C448Y mice). In Aim 1, these models will be
individually crossed with mice that selectively express eGFP in corticospinal motor neurons (CSMN), so that
loss-of and gain-of-function contributions to the disease can be investigated. In Aim 2, FAT deficits will be studied
in neurons cultured from these animals, and specific hypotheses for the etiology of the deficits will be tested. In
Aim 3, studies are proposed using transgenic spastin-C448Y mice in which autophagy is experimentally
enhanced or CK2 levels are experimentally reduced, to test the hypothesis that these manipulations will prevent
or reduce corticospinal axon degeneration and associated behavioral deficits. The overall significance of this
project is to establish mechanisms underlying SPG4-HSP and forge a path toward effective therapies for
patients.

Public health relevance
PROJECT NARRATIVE Hereditary Spastic Paraplegia (HSP) comprises a group of rare heritable neurological disorders characterized by progressive lower extremity weakness and spasticity resulting from the gradual degeneration of long axons projecting from corticospinal motor neurons (CSMN). While it is known that the most common form, termed SPG4-HSP, is caused by mutations of SPAST, the gene encoding the microtubule-severing protein spastin, the mechanistic basis for the disease remains unknown. Based on novel mechanistic hypotheses, the proposed work utilizes a wide variety of contemporary techniques (including the development and use of novel reporter mouse models) to evaluate mechanisms linking SPAST mutations to CSMN degeneration.